Microbiota, Metabolites, and Colon Neoplasia

Project Summary
The human diet can positively or negatively impact cancer incidence, with plant-derived compounds – such as
polyphenols – often exhibiting antioxidant cancer-preventive properties. Walnuts are an exceptional source of
polyphenolic ellagitannins (ETs) that are converted to ellagic acid and various urolithins by gut microbiota in the
colon. Urolithin A (UroA) is of particular interest for its potent anti-cancer, anti-inflammatory, and prebiotic
activities. However, UroA production in individuals can vary significantly, likely based on differences in gut
microbiota. We will substantiate the anti-cancer benefits of a prebiotic/probiotic complex derived from consuming
walnuts and determine the basis of human inter-individual variability in UroA formation.
Our overall hypothesis is that walnut supplementation improves colonic health and lowers colorectal cancer
(CRC) risk through UroA formation. This leads to several working hypotheses guiding our Aims: Working
Hypothesis 1. UroA producers are at a lower risk of having an advanced colonic lesion; Working Hypothesis 2.
Walnut supplementation will increase urinary UroA levels; and Working Hypothesis 3. CRC prevention by
walnuts will be greater in UroA-producers than in non-producers. In Aim 1, we propose a randomized, controlled
crossover trial in 69 patients (45-75 y) to examine walnut effects on CRC risk factors. We will associate an
individual's ability to produce UroA with biomarkers of inflammation and CRC risk, and identify the bacterial
species responsible for urolithin metabolism. In Aim 2, we will investigate prebiotic effects of ET-containing
walnuts in two conditional mouse CRC models, focusing on important processes in CRC and inflammation,
including bile acid metabolism, inflammation, and short chain fatty acid production. In Aim 3, we will test the
probiotic effects of human UroA-producing microbiota in a mouse fecal microbiota transplant (MT) study and
demonstrate a causal role for specific microbes in UroA formation. This will enable us to validate the concept that
important protective effects of walnuts and other ET-rich foods occur through specific microbiota-derived
metabolites. This will also define biomarkers and probiotics that highlight the benefits of these foods. Our
approach incorporates personalized nutrition with a focus on UroA producers and non-producers in colonic
health. Ultimately, our human and pre-clinical mouse studies may lead to prebiotics and probiotics that increase
protective urolithins for CRC prevention. These highly significant studies will test the ability of the microbiota to
generate colonic mucosa-protective agents (e.g., UroA). It is possible that high-risk patients can be efficiently
converted to a protective state by taking probiotics to realize the full benefits of ET-rich foods.

Public health relevance
NARRATIVE Our approach incorporates personalized nutrition within the context of colonic health and focus on UroA producers and non-producers. Ultimately, our human and pre-clinical mouse studies may lead to prebiotics and probiotics that increase protective urolithins for CRC prevention. These studies are of high significance as they will test the ability of the microbiota to generate agents (e.g., UroA) protective of the colonic mucosa, converting high-risk patients to a protective state by taking probiotics, thereby realizing the full benefits of ET-rich foods.